MYCOPHENOLATE MOFETIL IN PRIMARY SCLEROSING CHOLANGITIS

To determine if Mycophenolate Mofetil can improve biochemical, histologic and or cholangiographic features of primary sclerosing cholangitis and be of possible benefit for treatment of this disease